Optimizing FACED for robust large-scale activity recording

SUMMARY/ABSTRACT
A longstanding challenge in neuroscience is how to monitor neuronal signaling and activity at cellular resolution over a large area/volume with millisecond time resolution. At high frame rates, conventional two-photon fluorescence microscopy (2PFM) methods are limited in their achievable fields of view by their point-scanning mechanisms. Although camera-based one-photon widefield fluorescence microscopy (1PWM) can be used to image fast activity events at kilohertz frame rates, it requires sparse fluorescence labeling/excitation and is limited to superficial tissue depths. Previously, we implemented an all-optical and passive ultrafast laser-scanning technique called free-space angular-chirp-enhanced delay (FACED) in 2PFM. Capable of generating millions of line scans per second, our FACED module has enabled 2PFM to image large fields of view at kilohertz frame rates. Applying FACED 2PFM to the mouse brain in vivo, we recorded supra- and sub-threshold electrical activity and characterized ultrafast cortical blood flow dynamics deep below the brain surface. Here, we aim to further optimize FACED technology to maximize its accessibility and impact. First, we will develop a FACED module with fully motorized positioning and active beam stabilization, to enable alignment-free operation with flexible configuration. We will also build software support for FACED data acquisition into ScanImage, a widely used 2PFM control program. Together, the development of user-friendly hardware and software will facilitate the adoption of FACED in labs that specialize in biological applications. Next, we will expand the impact of FACED on fast neural imaging into the mesoscale by integrating a FACED module into a two-photon mesoscope, with the resulting 10-30× speed gain enabling the recording of neuronal activity over 20 mm2 in vivo. Finally, to overcome the limitations of 1PWM in voltage imaging, we will build a kilohertz-frame-rate single-photon confocal microscope using FACED to enable voltage imaging in both sparsely and densely labeled brains, while developing new far-red voltage sensors to maximize the imaging depth of this approach. The proposed work will substantially broaden the impact of FACED technology by making it accessible to and capable of answering a wide variety of neuroscience questions.

Public health relevance
NARRATIVE An optical module that scans millions of lines per second was combined with two-photon fluorescence microscopy to record neural activity at kilohertz frame rates. Further optimizations of this module, including hardware stabilization, software integration, and implementations in novel microscopy modalities will be pursued to maximize its accessibility and achieve robust large-scale recording of neural activity.